Decision Making in Metoidioplasty and Phalloplasty Gender Affirming Surgery (MaPGAS)

Project Summary/Abstract
Metoidioplasty and phalloplasty gender affirming surgeries (MaPGAS) are increasingly performed but
remain high risk procedures that require patients to make complex decisions affecting future gender
congruence, fertility, urinary, and sexual function. Prior studies demonstrate there is decisional uncertainty
among transgender and non-binary individuals assigned female at birth considering MaPGAS which may lead
to poor decision quality and outcomes. In these high risk surgical decisions with multiple options with clinical
equipoise, it is paramount to empower patients with decision support that facilitates quality decisions that are
well informed, deliberated, and align with personal goals and values. However, there is a lack of validated
MaPGAS decision support due to a historical lack of understanding of patients’ decisional needs and dearth of
high quality published outcomes or guidelines. Taken together, this limits the extent of MaPGAS counseling
and shared decision making, potentially leading to poor quality decisions and unexpected outcomes.
In our prior R21 we used a mixed methods design grounded in the Ottawa Decision Support
Framework with community and provider stakeholders, to identify key themes surrounding patient surgical
goals, values, and decision moderators from geographically diverse locations in the US. This was combined
with a systematic review of the literature and modified Delphi consensus of high volume MaPGAS surgeons
on patient focused surgical outcomes to create, iteratively revise, and sandpit test a community developed,
web-based MaPGAS picture decision aid (DA) prototype. The DA provides information on the most common
MaPGAS options and a decision support tool applicable to patients of various health literacy levels.
The purpose of this study is to 1) evaluate the usability and acceptability of the MaPGAS DA using a
mixed methods approach including the validated System Usability Scale triangulated with key stakeholder
focus groups feedback. Further, to 2) evaluate preliminary MaPGAS DA efficacy through a prospective
randomized controlled trial at two geographically diverse institutions. The primary outcome includes change in
pre and post DA decisional conflict (Decisional Conflict Scale) and decision readiness (Preparation for
Decision Making Scale) as compared to usual care. The secondary outcome will include post-surgical
consultation evaluation with the CollaboRATE measure coupled with semi structured patient and provider
interviews on optimal DA administration timing, implementation, and impact on shared decision making.
Successful completion of this study will refine the MaPGAS DA, test preliminary efficacy, and inform a
larger prospective study designed to test broader acceptability, efficacy, and ultimately improve MaPGAS
shared decision making.

Public health relevance
Project Narrative Metoidioplasty and Phalloplasty Gender Affirming Surgeries (MaPGAS) are complex, high risk procedures that require patients to make several decisions affecting long term gender congruence, fertility, urinary and sexual health. Many patients considering MaPGAS have decisional uncertainty without access to validated decision support which limits the quality of shared decision making, potentially leading to poor quality decisions and unexpected outcomes. The purpose of this study is to 1) evaluate the usability, acceptability, and 2) preliminary efficacy of a novel, community developed web based MaPGAS decision aid designed to reduce decisional uncertainty, improve decision readiness, and facilitate quality MaPGAS shared decision making.